Innovative closed-loop functional electrical stimulation control system for augmenting post-stroke gait

PROJECT ABSTRACT
Functional electrical stimulation (FES) is a common rehabilitation technology that incorporates electrical
stimulation timed with a functional task to augment paretic muscle function in people with neuro-pathologies
such as stroke and spinal cord injury. The rigor of previous research has established transcutaneous and
implanted FES systems for standing, walking, reaching and grasping, with both neuro-prosthetic and
therapeutic effects. Stroke is the leading cause of disability. Footdrop is a highly prevalent post-stroke gait
deficit, leading to insufficient ankle dorsiflexion during the swing phase of gait, and contributing to reduced
mobility. FES systems that compensate for footdrop to improve gait function and reduce falls risk are gaining
increasing popularity, with commercial FES footdrop systems now available for clinical use. Despite their
promising functional value, accessibility, and positive neuroplasticity effects, current FES systems have some
fundamental limitations, which limit their clinical prescription. The overall goal of this R21 is to overcome 2
major limitations and technical gaps in FES – rapid onset of muscle fatigue and lack of closed-loop control of
FES intensity. Most existing FES systems do not automatically modulate stimulation intensity in response to
muscle fatigue, and may overstimulate the muscles. To address this limitation, this R21 facilitates a novel inter-
institutional cross-disciplinary collaboration between scientists with complimentary expertise in clinical testing
of FES for improving stroke gait (MPI Kesar) and engineering of data-driven FES control systems (MPI
Sharma). We propose the first clinical testing of a new bioinspired FES controls approach developed by MPI
Sharma that exploits fatigue predictions from a model-predictive controller (MPC) to control FES intensity,
avoid overstimulation, delay fatigue, and maximize FES-induced gait performance. For the first time, we will
systematically test FES controllers that incorporate MPI Sharma’s data-driven MPC muscle and fatigue
behavior model in people with post-stroke hemiparesis, so that FES parameters can be computed optimally
and proactively, via prediction (feedforward FES control), in addition to reacting to changes in ongoing gait
performance (feedback FES control). For this MPC-based FES controller, we propose to use ultrasound to
inform the model about fatigue onset, which is unprecedented in FES for stroke gait. Our project aims are to
(1) develop and evaluate a novel data-driven, model predictive FES controller that utilizes ultrasound-
derived feedback for footdrop correction during post-stroke gait; and 2) compare our novel FES
control system with conventional FES during treadmill and overground gait in people post-stroke. This
work will inform future clinical testing and development. Our immediate deliverable will be a leading-edge FES
neuro-prosthetic technology that uses ultrasound-sensing and MPC closed-loop optimization of FES
stimulation to improve mobility in people post-stroke. The sustained impact will be development of FES
systems that enable fatigue resistant mobility in people post-stroke and other neuro-pathologies.

Public health relevance
NARRATIVE Functional electrical stimulation (FES) is a non-invasive and clinically-feasible technology that uses electrical stimulation to replace or enhance the function of weak or paralyzed muscles. This project will develop and test a new engineering technique to automatically control intensity delivered by FES systems by using new sensing technology (portable ultrasound) to track muscle performance and a new type of automatic controller (data- driven mathematical model that predicts fatigue). By conducting the first evaluation of this novel FES control system in stroke survivors who have footdrop, this work will take an important step toward the long-term goal of using FES to maximize walking function and reduce disability in people with stroke and other nervous system disorders.